Transcriptional networks governing A. fumigatus virulence

Abstract
Invasive infections due to Aspergillus fumigatus are increasing and are still associated with unacceptably high
mortality, even with new therapies. Our understanding of A. fumigatus infection biology is limited. Among 10,180
predicted genes in the A. fumigatus genome, over 95% are uncharacterized, and fewer than 100 genes have
demonstrated roles in virulence. It is critical to identify genes that govern virulence and the pathways in which
they act because they can point to high priority targets for therapeutic and diagnostic development. We have
identified a transcriptional regulator in A. fumigatus, WrpA, that shares limited homology with Candida albicans
Wor1 and Histoplasma capsulatum Ryp1. Our preliminary data indicate that WrpA governs the capacity of A.
fumigatus to withstand macrophage killing, grow under hypoxic conditions, and invade and damage pulmonary
cells in vitro. ΔwrpA deletion mutants have highly attenuated virulence in the mouse model of invasive
aspergillosis. Using RNA-seq, we found that WrpA governs the expression of ~15% of genes in the A. fumigatus
genome, including multiple transcription factor genes. Our premise is that the WrpA is a master regulator that
governs host cell interactions and virulence. In support of this premise, our initial investigations of the WrpA
regulon have already revealed novel pathogenicity-related functions of three WrpA-dependent transcription
factors, SrbB, Fcr1, and Ndt80. Our goal is to characterize the WrpA regulon in A. fumigatus and to identify
downstream effector genes whose products mediate pathogenicity by: 1) identifying the transcription factors that
are directly regulated by WrpA and determining their roles in pathogenicity; 2) analyzing selected WrpA-
dependent transcription factors and identifying their downstream target genes; and 3) determining the function
of effector genes controlled by the WrpA regulon and investigating their roles in virulence. The results of the
experiments described in this proposal will enable us to characterize a key transcriptional regulator that governs
A. fumigatus pathogenicity and then use this information to identify downstream effector genes, the products of
which mediate host cell interactions and virulence. The results of this work will not only provide foundational
understanding of A. fumigatus virulence mechanisms, but also hold promise to identify new diagnostic,
therapeutic, and vaccine targets.

Public health relevance
Narrative Aspergillus fumigatus is the principal cause of invasive aspergillosis, which is a frequently deadly and increasingly common disease in immunocompromised patients. The goal of this project is to characterize a novel transcriptional regulator in A. fumigatus that governs host cell interactions and virulence and to discover the downstream effector genes that are controlled by this regulon.